Extending inferences of efficacy and selection of transformative diabetes therapies to diverse populations

ABSTRACT
Type 2 diabetes mellitus (T2D) is a common chronic disease associated with morbid and costly complications.
New medication classes – glucagon-like peptide-1 receptor agonists (GLP1RA) and sodium-glucose
cotransporter-2 inhibitors (SGLT2i) – have proven cardiovascular, renal, and glycemic benefits in randomized
clinical trials (RCTs) in individuals with T2D. RCTs provide high quality evidence of efficacy yet leave several
evidence gaps relevant to routine clinical care. First, while a well-conducted RCT has strong internal validity,
the applicability of the results in real-world care – or external validity – can be uncertain, particularly for
populations underrepresented in the RCT. Unfortunately, minoritized race and ethnicity groups and rural
individuals bear excess burden of T2D and T2D complications but are underrepresented in recent RCTs of
GLP1RA and SGLT2i. Second, most Phase 3 RCTs for GLP1RA and SGLT2i utilize a placebo control. As a
result, there are little to no head-to-head data comparing efficacy and harms of GLP1RA and SGLT2i for
cardiovascular and kidney endpoints – potentially valuable data for routine diabetes care. Finally, RCTs are
designed to estimate an average treatment effect in the trial population but are typically underpowered to
identify heterogeneous treatment effects or subgroups in which one treatment or another has particular benefit
or risk of harm. Moreover, prediction models to guide T2D treatment selection may not generalize well across
populations – similar to the problem of RCT external validity. The overall goal of this proposal is to bring
together real-world data from diverse T2D populations from three health systems and data from pivotal RCTs
of GLP1RA and SGLT2i to address each of these evidence gaps using biostatistical tools known as
transportability methods. Transportability methods use weighting to balance participant characteristics between
a clinical research study population (e.g., an RCT) and a target population (e.g., individuals with T2D from a
population underrepresented in an RCT). This allows inference of what the study’s results would have been
had the target population participated in the study. Importantly, these methods avoid several critical threats to
validity of conventional comparative effectiveness research methods. In Aim 1, transportability methods will be
used to extrapolate the efficacy and harm of GLP1RA and SGLT2i from recent landmark RCTs to
representative real-world samples of T2D patients and to populations underrepresented in RCTs. In Aim 2,
extensions of transportability methods will be used to estimate head-to-head effects of GLP1RA and SGLT2i
for glycemic, cardiovascular, and kidney outcomes. Aim 3 will focus on developing prediction models to guide
individualized selection of GLP1RA versus SGLT2i and utilize transportability methods to improve prediction
model performance across diverse populations. In completing the Aims, the study will create a roadmap that
describes best practices for designing and executing transportability analyses and will provide insights into how
RCT and real-world data can be integrated to generate timely evidence relevant to all individuals with T2D.

Public health relevance
NARRATIVE Real-world data from populations receiving routine health care are typically more representative of individuals with a clinical condition than data from clinical research studies, including clinical trials. The goals of this proposal are to evaluate how integrating clinical research study data and real-world data can, first, improve evidence of efficacy and safety in representative patient populations, including those underrepresented in clinical trials; second, provide valuable head-to-head data on recently approved medications even in the absence of gold-standard clinical trials comparing the medications of interest; and third, help develop treatment selection tools that help clinicians and patients select the best medication for them. The results of the research will provide guidance on when and how real-world data can enhance evidence from clinical research studies of new medications in representative populations.